LIPID AND LIPOPROTEIN METABOLISM IN ATHEROSCLEROSIS

To study differences between people to learn how to alter the course of atherosclerosis (narrowing and hardening of the arteries). Blood is drawn from normal subjects and those with a variety of illnesses. To develop techniques to study and individual's cholesterol metabolism and advise regarding prevention of atherosclerosis.